Developing and Enacting Racial/Ethnic Identities

[unreadable] DESCRIPTION (provided by applicant): The proposed research is focused on the development, maintenance, and consequences of racial and ethnic [R/E] identity among a primarily African-American and European-American sample from a mid-Atlantic state, with continued analyses and a new data collection which will allow for the examination of R/E identity, related processes, and healthy development from early adolescence (approximately age 12) through early adulthood (approximately age 30). We propose a multi-year, mixed-methods research project that examines the personal and contextual meanings that (a) are associated with participants' categorical R/E group memberships, (b) form the basis for person-level R/E identities, (c) are associated with perceptions of racial discrimination, and (d) relate systematically to healthy development. The first major aim is to document the nature of R/E group memberships (defined by both individuals and social groups), the extent of psychological meanings attached to these group memberships (i.e., R/E identity), and the corresponding developmental pathways (defined by both R/E identity and indicators of healthy mental, physical, and social development). The second major aim is to examine how R/E identity structures and processes moderate the relations between race-based social stressors and optimal human development. The primary hypothesis we plan to test is that the effects of perceived racial discrimination on healthy development will vary systematically as a function of the content, structure, and processes of individuals' R/E identities (e.g., beliefs, feelings, and values about socially-constructed, group-membership categories). We also want to document empirically the extent to which adolescent psychological R/E identity development matters for continued R/E identity development during early adulthood and for healthy adult functioning. [unreadable] [unreadable] [unreadable] [unreadable]